PHYSIOLOGIC BIOMARKERS PREDICTING VENTILATORY INSTABILITY AND HYPOXEMIA IN PREMATURE INFANTS

PROJECT SUMMARY The proposed study is a longitudinal cohort study of 100 to 110 preterm infants born between 24 and 28 weeks gestation. It is designed to explore the contribution of delayed or aberrant ventilatory control to the need for continued respiratory support at 8 to 12 weeks of age.. Infants will be categorized according to why they seem to need respiratory support, using challenge studies. Ventilatory control will be further investigated using novel techniques for calculation of loop gain of the respiratory system and to explore the links between abnormalities seen by magnetic resonance imaging (MRI) ands aberrant ventilatory control. The proposed studies are also designed to help clarify the indications for airflow support, supplemental oxygen therapy and a ventilatory stimulant ? caffeine ? as these infants grow and mature.

Public health relevance
PROJECT NARRATIVE In the USA each year, 500,000 infants are born prematurely. Surfactant treatment that keeps their lungs expanded has markedly improved these babies' outlook. But because they are immature, their breathing pattern can be irregular, causing them to become low in oxygen, and sometimes their breathing stops for many seconds. This study of over 100 premature infants is designed to develop better tests to identify babies at risk for irregular breathing pattern, and to use the tests to pick better treatments.